Cell-Cell and Cell-Matrix Interactions in Morphogenesis

DESCRIPTION (provided by applicant): The primary goal of the proposed research is to elucidate mechanisms responsible for the coordination of collective cell movements that, in turn, are required for proper tissue assembly and morphogenesis. During vertebrate gastrulation, a dramatic series of cellular rearrangements culminates in the segregation of germ layers and the establishment of the vertebrate body plan. As these events unfold, the cells and tissues involved generate and respond to mechanical forces that are borne by both cadherin and integrin adhesions. Few studies have attempted to link this ebb and flow of mechanical signals to the emergence of specific motile behaviors of individual cells or groups of cells in vivo. Our overall hypothesis is that mechanical forces play an essential instructive role in morphogenesis by organizing and directing the cellular behaviors responsible for bulk tissue movements including the collective migration of cells on extracellular matrix (ECM) substrates. Using the mesendoderm of the amphibian Xenopus laevis as a robust model for collective cell motility, we have discovered a novel mechanically-responsive cadherin complex with links to the keratin intermediate filament (KIF) cytoskeleton. These cadherin-dependent cell-cell adhesions resist and balance integrin-dependent traction forces generated at the front of each cell. The resulting force anisotropy is crucial to the organization of collective cell movements in the mesendoderm. In this project period we will determine the steps involved in directing cell protrusive activity i response to tugging forces on cadherins and establish the contributions of intermediate filaments to this process. There are three specific aims. The first will establish the relationship between cadherin tugging forces and activation of the Rho family GTPase Rac1. We will address the hypothesis that there is an antagonistic relationship between Rac activity and the KIF cytoskeleton that regulates protrusive activity in these cells. The second aim will establish the relative contributions of two types of forces to the progressive closure of the circular mesendoderm tissue: distributed traction stresses generated by individual cells on fibronectin vs. contractile forces generated by the circumferentially arranged cells at the leading-edge of the tissue. The final aim will employ optically based approaches to selectively perturb cadherin linkages to either the actin or keratin filament cytoskeletons. These studies will address the functional importance of the cadherin-KIF complex to mechanosensing, regulation of polarized protrusive activity, crosstalk with integrin-ECM adhesions, and the coordination of collective cell migration. This research has broad relevance to fundamental problems of tissue regeneration and repair, normal tissue morphogenesis and its dysregulation in diseases, which include cancer and metastasis.

Public health relevance
PUBLIC HEALTH RELEVANCE: The movement of cells from one location to another is a fundamentally important process that begins when we are embryos and continues throughout adult life. Cell migration helped build many of our tissues and organs, contributes to wound healing and plays an important role in fighting infections. Many diseases progress because of cell movements that have gone awry, for example, during the migration and spread of cancer cells from a tumor. The machinery of cell migration is complex but uncovering the many steps involved in normal cell migration, key to understanding where the process goes wrong during disease. This research will extend our knowledge of the signals involved in controlling cell migration and, thus, will contribute to the development of future therapies that may help promote (e.g., wound repair and tissue regeneration) or inhibit (e.g., cancer metastasis) cell migration.